Diabetes, Endocrinology and Metabolism

DESCRIPTION (provided by applicant): This Training Grant, entering its 31st year, has a multidisciplinary faculty from both basic science and clinical departments within the School of Medicine. The training program is designed to offer trainees a unique and supportive environment in which to learn innovative approaches to the study of Endocrinology, Diabetes and Metabolism. The trainees will pursue research in laboratories where established and cutting edge research programs take advantage of a spectrum of approaches ranging from molecular, cellular, and animal models to human subjects. Advanced molecular and genetic techniques as well as classical clinical protocols and epidemiology are used to develop novel concepts and tools for the study of the physiology, pathophysiology and treatment of diseases of endocrinology, diabetes and metabolism. The training faculty includes 12 investigators from 6 departments- Medicine/Endocrinology, Pediatrics/Endocrinology, Obstetrics/Gynecology, Urology, Developmental Biology and Genetics- whose interests converge on 3 endocrinologic themes. Theme #1 Hormone Receptors/Signaling Pathways includes projects in the labs of: Barsh, Chawla, Conti, Feldman, Hoffman, Hsueh, Kim, Kraemer, Peehl. Theme #2 Genetics/Hormone-Dependent Cancer includes projects in the labs of Barsh, Chawla, Feldman, Hoffman, Hsueh, Kim, Peehl, Reaven, Stefanick. Theme #3 Diabetes-lnsulin/Lipids/ and Cardiovascular Risk included projects in the labs of: Barsh, Chawla, Kim, Kraemer, Reaven, Stefanick, and Wilson. Thus trainees have a wide choice of research projects but with a focus on several major lines of research. This Training Grant has been the core of the Endocrinology teaching program at Stanford providing support for 5 post-doctoral trainees, with either the M.D. or Ph.D. degrees. In addition to research training, the Training Grant in conjunction with the medical school provides a rich environment of seminars, courses and conferences as well as core facilities all fostering a stimulating and productive training program with major interaction between trainees and mentors. The Training Grant faculty are committed to recruiting a diverse group of trainees and make strong effort to enlist trainees from under-represented minorities. Programs in the ethics of responsible research, grant writing, critical evaluation of the literature as well as many other courses and seminars enrich the training program.